Regenerative pathways in the avian cochlea

Project Summary / Abstract
It is known for more than 30 years that supporting cells in the normally quiescent avian hearing organ, the
basilar papilla, can respond to sensory hair cell death with S-phase entry, mitotic division, and generation of
replacement hair cells. The work proposed here utilizes several methodological advances for an unbiased,
comprehensive, and systematic inventorying of changes in gene expression during aminoglycoside-induced
hair cell death and in responding supporting cells. Pilot data obtained at multiple time points from single cells
isolated from the chicken basilar papilla sensory epithelium revealed that activation of a novel pathway linked
to protease-activated receptor-2, PAR2, is essential for S-phase entry of supporting cells and hair cell
regeneration. The project puts forward a speciﬁc hypothesis for the activation pathway, which will be explicitly
and thoroughly evaluated. Moreover, the identiﬁed eﬀector genes for the novel regeneration pathway will be
assessed in a new adult mouse model for long-term hair cell loss. Here, the focus is on S-phase entry of
mouse utricle and organ of Corti supporting cells four weeks after aminoglycoside-induced hair cell loss.
Finally, the project will focus on the characterization of newly regenerated hair cells by reconstructing the
temporal transcriptomic changes that happen when the new hair cells mature. In parallel, it is proposed to
align transcriptomic data with in situ observations such as hair bundle formation, changes in planar cell
polarity, reestablishment of synaptic connections, and electrophysiological features such as
mechanoelectrical transduction and electrical tuning.

Public health relevance
Project Narrative This project utilizes single-cell RNA sequencing data and a novel damage model that synchronizes the regenerative responses of supporting cells during proliferative sensory hair cell regeneration in the chicken hearing organ, the basilar papilla. Among the identified signaling pathways is one essential for S-phase entry of supporting cells during hair cell regeneration, and it is proposed to translate the findings towards adult mammals and evaluate regeneration in vestibular and cochlear organs. Finally, the re-establishment of proper hair cell-type specificity, hair bundle differentiation and function, tonotopic integration, and neural connection of regenerated avian hair cells will be characterized in-depth.